Core A: Administrative Core

ADMINISTRATIVE CORE, CORE A: SUMMARY
The Administrative Core (Core A) is directed by Roy Herbst and Katerina Politi, Principal Investigators of the
Yale SPORE in Lung Cancer (YSILC), and co-directed by Anna Arnal Estapé, with support from the program
financial management team. Careful oversight by the Administrative Core will be critical to ensure the success
of the Yale SPORE in Lung Cancer. Core A works side by side with the Yale Cancer Center (YCC) Research
Administration to support and facilitate transdisciplinary research efforts. The Administrative Core serves as the
central coordination point for all YSILC investigators, with responsibility for monitoring the progress of all projects
and cores towards a translational/clinical endpoint. The Core Directors and Co-Director have responsibility for
leading the YSILC program, setting translational research priorities, identifying new translational research
opportunities from emerging data, monitoring the progress of all projects, cores and developmental projects and
determining changes in direction of projects, cores and translational research as needed. Interactions among
YSILC investigators is facilitated by Core A to accelerate the translation of laboratory findings into the proposed
and future clinical studies. If required, the Core A Directors will manage conflicts among YSILC investigators. As
a team, the Core personnel monitors finances, maintains communications among project and core leaders and
coordinates meetings, including the monthly SPORE meeting series, monthly meetings of the Executive
Committee, annual meetings of the Internal/External Advisory boards and the annual YSILC CEP and DRP
Symposium. In addition to these functions, the Core is the primary interface with the NCI, other lung cancer
SPOREs, YCC and Yale University, and coordinates outreach efforts, including publications (internal and
external), website development, seminars, patient/research advocacy activities, and fundraising programs.
Through these administrative activities, Core A is essential to the organization of the YSILC program, to fostering
a widespread culture of lung cancer basic/clinical/translational research at Yale and to the efficient achievement
of the stated program objectives, with the ultimate goal of a significant clinical impact for patients with lung cancer.